Evidence For Endothelial Involvement in Idiopathic Nephrotic Syndrome: A Role for CD93

Project Summary/Abstract: Idiopathic Nephrotic Syndrome (INS) is the most common type of nephrotic
syndrome in childhood, yet its cause remains unknown. Most authorities consider the disease to be mediated
by an unknown circulating factor that directly binds the podocyte, causing podocyte activation and proteinuria.
However, our group has shown that the disease may not be that simple and that there is also injury to the
glomerular endothelial cells (GEnC) that line the inside of the capillary. We recently showed evidence of
circulating endothelial biomarkers in ~90% of INS patients. In preliminary studies, we found that one specific
endothelial protein, CD93, was especially important, which may relate to its ability to activate focal adhesion
kinase (FAK), a protein that is activated in INS and causes podocyte injury. We found high CD93 expression in
GEnC from kidney biopsies of INS patients and that levels of its soluble form were high in serum and urine in
~90% of ~300 patients. We also found that sera in relapse stimulate cultured GEnC to release CD93; and
importantly, that activation of podocytes by relapsing sera could be blocked with an antibody to CD93. Our
preliminary work also identifies urinary CD93 as predictor of kidney disease progression. Our data suggest that
the pathogenesis of INS involves an intermediary step of GEnC activation that facilitates podocyte injury.
Our central hypothesis is that circulating factors activate GEnC to release the soluble form of CD93, which, in
turn, acts as (1) a predictive biomarker for kidney disease progression, and (2) mediator of podocyte activation
via FAK signaling. In aim 1, we will study whether CD93, in glomeruli, urine or serum, predicts clinical outcomes
and associates with structural and/or biological changes affecting glomeruli. This will be complemented by pilot
studies to delineate the patterns of soluble CD93 across disease states, and its specificity across glomerular
diseases. In aim 2, we will combine multiple in vitro approaches to identify the source of soluble CD93 and its
effects on human podocytes. In aim 3, we will study the CD93 involvement in 2 classic animal models of INS
(puromycin and adriamycin), and whether CD93 blockade prevents and/or mitigates proteinuria.
Our hypothesis is innovative because GEnC are not considered to have an important role in INS. The
combination of several approaches to assess endothelial injury and the inclusion of a large population
provide rigor to the clinical studies. Integrating multiple cell systems and classic models of INS also provide
a rigorous approach to test causality. Our proposal is highly translational and could lead to the identification
of a novel prognostic and therapeutic target in INS. A four-year mentored career development plan has also
been devised, which incorporates training in endothelial biology, precision medicine, and leadership by an
experienced mentoring and advisory teams. The candidate’s long-term career goal is to become an
independent investigator discovering biomarkers, mechanistic pathways, and targeted therapies in INS.

Public health relevance
Project Narrative: Idiopathic Nephrotic Syndrome (INS) is a devastating kidney disease for children, and the cause is unknown. Here we propose a novel role for the endothelial cell, a cell type that lines the inside of blood vessels. We will investigate the role of endothelial cells, and especially the endothelial molecule CD93, in INS using a combination of cell culture, animal models and human studies, with the goal of not only getting a better understanding of what causes the disease, but also potential ways to prevent or treat it.